Microfluidic device for detection of infectious prion proteins

Project Abstract
Transmissible Spongiform Encephalopathies (TSEs) are 100% fatal neurodegenerative disorders caused
by prion protein misfolding. These diseases, including Creutzfeldt-Jakob disease (CJD) in humans, bovine
spongiform encephalopathy in cattle, scrapie in sheep and goats, and chronic wasting disease in cervids,
pose significant public health risks due to their transmissibility, especially through medical procedures
(organ transplants and blood transfusions). The rising incidence of CJD in the United States, and the
potential for animal to human infection, further intensifies these concerns. Diagnosis of TSEs is
challenging, with autopsy often being the gold standard for confirmation in humans. Current molecular
detection methods for misfolded proteins, such as Real-Time Quaking Induced Conversion (RT-QuIC), are
limited in availability and not well-suited for point-of-care use. In response to this critical need, Priogen
Corp. has developed and patented an advanced point-of-care microfluidic device, Micro-QuIC, which
leverages microfluidic channels and acoustic wave technology to rapidly detect misfolded prion proteins
using fluorescent dyes such as thioflavin T. This approach builds upon proven principles of fluorescent
detection of TSEs through solution agitation. However, current Micro-QuIC prototypes depend on bulky lab
equipment, are not feasible for commercial production and have only been demonstrated with one TSE. In
this Phase I STTR proposal, Priogen Corp. will partner with the University of Minnesota to refine
Micro-QuIC into a scalable, rapid, portable, point-of-care microfluidic device for TSE detection. The project
will be achieved through the following Specific Aims: (1) to optimize the Micro-QuIC assay to distinguish
between native and misfolded prions within 6 hours, (2) to develop a self-contained Micro-QuIC device by
integrating an acoustic frequency generator and a fluorescence detection system into a portable docking
station, and (3) to demonstrate the utility of Micro-QuIC across various TSEs. The successful
implementation of the Micro-QuIC system will revolutionize TSE detection, offering rapid, accessible, and
reliable testing. This innovation holds immense potential for improving public health safety by enabling
early detection and management of TSEs in both human and animal populations.

Public health relevance
Project Narrative Transmissible spongiform encephalopathies (TSEs), such as Creutzfeld-Jakob disease (CJD) in humans, bovine spongiform encephalopathy in cattle (which can also infect humans causing variant-CJD), and chronic wasting disease in cervids, are 100% fatal protein misfolding diseases with no widely available diagnostic options for early detection. Diagnostic limitations ultimately contribute to the spread of TSEs and hinder the development of effective therapeutics. Priogen Corp. proposes to develop a microfluidic protein amplification diagnostic platform (Micro-QuIC) as a point-of-care testing option, which will facilitate early, accurate detection of TSEs, significantly reducing the window for disease transmission and improving patient recruitment into therapeutic clinical trials.